PEACE Platform for Non-Invasive Narrative Neuromodulation (Personalized Evocative Audiovisual Content for Everyone)

PROJECT SUMMARY/ABSTRACT
The opioid epidemic continues to be a significant public health crisis, with the death rate from
opioid overdoses rising an average of 7% a year for over a decade in the United States.
Innovative approaches that focus on enhancing emotional regulation and resilience are needed
to complement existing treatment strategies. The PEACE Platform is a novel solution that
leverages personalized audiovisual content and machine learning algorithms to help individuals
with opioid use disorders (OUDs) build their capacity to manage negative emotions and
stressors. The platform generates tailored content and uses objective physiological data from
wrist wearables to identify the likelihood that an individual's reactions to the content are positive
and uplifting. By combining generative artificial intelligence, predictive analytics, and
physiological data, the PEACE Platform offers a precision medicine tool that creates and
recommends content to support emotional well-being and resilience in the context of OUD
treatment.
The research design involves the development and evaluation of the PEACE Platform, including
the integration of machine learning algorithms, biometric data analytics, and user experience
optimization. The methods will include a combination of data analysis, user testing with patients
and providers, and software development to assess the usability and feasibility of the PEACE
Platform as an adjunct to existing OUD interventions.

Public health relevance
PROJECT NARRATIVE Over 100,000 people died from drug overdoses in the United States in 2021 and drug overdoses are costing the U.S. economy over $1 trillion each year. The PEACE Platform will empower people with opioid use disorder to gain control over uncontrollable feelings which will benefit patients and treatment professionals by helping patients cope with distressing memories and strong negative feelings. An improved solution for opioid use disorder will save money and lives for municipalities, first responders, employers, public assistance insurance, courts, individuals, and families.